How Signaling Molecules Affect the Invagination and Posterior Migration of the Drosophila Salivary Gland

How Signaling Molecules Affect the Invagination and Posterior Migration of the
Drosophila Salivary Gland
The model organism Drosophila melanogaster serves as a valuable system for the
understanding of human congenital diseases. As the animal model with some of the most
sophisticated tools available for the purposes of genetic manipulation, it provides unlimited
potential for discovery of essential signaling pathways in organ formation and positioning. Our
laboratory utilizes the embryonic Drosophila salivary gland (SG), visible during the processes of
cellular invagination and directed cell migration through the use of fluorescent staining, as a
model of simple, unbranched epithelial tube formation analogous to formation of the human
digestive system and associated glandular tissues. Whereas the cellular mechanisms
contributing to the two key processes mentioned above have been described by our group and
others, the signaling pathways involved in their coordination remain largely undiscovered. We
hypothesize that the transcription factor Hückebein (Hkb) mediates localized secretion of the
signaling molecule gene encoded by folded gastrulation (fog) in the SG, activating a candidate
SG-expressed G-protein-coupled-receptor to coordinate apical constriction during tissue
invagination. We propose that Hkb-mediated trafficking of Fog and, potentially, its cognate
GPCR to the apical membrane is through Hkb-dependent transcription of the gene encoding the
kinesin-binding protein Klarsicht, which has been implicated in vesicle trafficking. We also seek
to uncover the signaling interactions between the SG and the surrounding tissues that mediate
its posterior migration, which our laboratory has previously determined to be the circular visceral
mesoderm (cVM), gastric caecae, somatic mesoderm, and fat body. We hypothesize that a to
be discovered ligand and receptor pair work together to initiate posterior migration of the
internalized SG along the visceral mesoderm, facilitating the reorientation of tube movement
from a dorsal to a posterior trajectory. Utilizing various tools of genetic manipulation, including
targeted gene silencing by RNA interference, gene disruption by CRISPR/Cas9 genetic editing,
in combination with tissue-specific misexpression by the Gal4/UAS system, I propose to test the
molecular mediators of the GPCR pathway involved in SG cell invagination and identify the
signaling molecules contributing to posterior migration of the internalized SG. This research will
help to uncover the roles of both autocrine and paracrine signaling in SG morphogenesis, and
perhaps even reveal developmental pathways contributing to the etiology of congenital diseases
in a variety of organisms.

Public health relevance
Project Narrative The fitness and, ultimately, survival of an organism requires proper formation and positioning of both simple and complex epithelial tubular networks. Using the embryonic salivary gland of Drosophila as a model system, I seek to understand the processes underlying key stages of epithelial tube formation. I focus on two distinct morphogenetic processes: 1) the pathway that determines the order of primordial cell invagination to initiate salivary gland tube formation and 2) the ligand-receptor signaling molecules involved in subsequent salivary gland tube placement within the whole organism.